Novel Methodologies for the Preservation (and Recovery) of Proteins at Low Temperature

ABSTRACT
The goal of this SC3 grant is to develop a novel method for the cryopreservation of proteins
without the use of co-solvents, which are usually employed to limit the structural changes that can
occur during freezing. The method exploits the glass polymorphism of water, i.e., low density
amorphous (LDA) and high density amorphous (HDA) glasses can be produced following specific
cooling/compression pathways. The pathways for storage and recovery of proteins will be studied
using non-equilibrium molecular dynamic simulations coupled to all-atom force fields. The central
hypothesis is that the density of the HDA will limit fluctuations in the solution upon cooling and the
protein will not undergo any significant structural changes when vitrified in HDA. The rationale
for the proposed research is that an understanding of the detailed mechanism by which proteins
are preserved in glassy water, can lead to the rational design of experiments that allow for more
controlled subzero protein preservation. In order to systematically develop this understanding
three groups of systems, with increasing order of structural complexity will be studied: (i) short
peptides with different secondary structures (ii) simple proteins that contain these secondary
structures within their tertiary structures, and (iii) two biomedically relevant proteins. The
information obtained from these studies has the potential to be extended to the storage of
pharmaceuticals, food, and biological cells without the use of co-solvents.

Public health relevance
NARRATIVE The successful cryopreservation of proteins requires the use of cryoprotectant molecules as co- solvents to prevent the formation of crystalline water, which can led to protein denaturation. This SC3 grant is centered around developing novel methods for the cryopreservation of biomolecules by exploiting the glass polymorphism in water, i.e., the existence two amorphous phases with different properties. Because our studies are based on non-equilibrium Molecular Dynamics simulations, these results will provide a fundamental understanding of the atomistic mechanism of protein preservation in glassy water without the use of co-solvents.